Enhanced Medication Management to Control ADRD Risk Factors Among African Americans and Latinos

Project Summary/Abstract
Alzheimer’s disease and related dementias (ADRD) disproportionately affects minorities – African Americans are 2x
more likely and Hispanics/Latinos are 1.5x more likely than white Americans to have ADRD. Recently, the Alzheimer’s
Impact Movement (AIM) and the Alzheimer’s Association supported the recommendation of “better management of risk
factors – particularly high blood pressure and diabetes – to reduce the risk of ADRD among African Americans and
Hispanics/Latinos.” Medications can be very effective in managing both hypertension and diabetes, but unfortunately
adherence to these medications is commonly low, particularly among African Americans and Hispanics/Latinos. Marginal
adherence (60%-80%) with anti-hypertensive medication is inadequate because these patients still had significantly
elevated risks (3x greater compared to fully adherent, 2.5x greater compared to highly adherent) of developing ADRD.
Hence, an effective pro-active solution for optimizing medication adherence can positively impact this patient
population.
The proposed solution will be a medication management service designed for providers. The full solution would
comprise of: (A) a commercially available electronic pill dispenser that sends SMS notifications of pills taken/missed, (B)
future adherence assessment based on historical data, and (C) a provider portal which presents adherence-related
information. To address the disparity in ADRD among African Americans and Latinos, the initial implementation will
specifically focus on providers who deliver care to older adults in these communities.

Public health relevance
Project Narrative The proposed solution will be a medication management service designed for providers. The solution will support the care of risk factors for Alzheimer’s disease and related dementia with older adults in the African American and Latino patient population.